RENAL HORMONES IN RENOVASCULAR HYPERTENSION

Purpose is to evaluate the role of angiotensin II, adenosine, catecholamines, atrial natriuretic factor, prostaglandins, PGE2, PGI2, and thromboxane on renin secretion and renal hemodynamics in patients with renovascular hypertension.